Molecular biophysics predoctoral training at the Ohio State University

PROJECT SUMMARY/ABSTRACT
The Molecular Biophysics Training Program (MBTP) at The Ohio State University (OSU) was formed in 2017 as
an organizing principle for training and interaction in molecular biophysics. OSU is a comprehensive public land
grant university, one of the largest in the nation, and nearly 20% of its students are from minority groups. OSU
has a strong group of researchers and attracts a strong student pool in molecular biophysics, but graduate
training and the research community were fragmented over several graduate programs, departments, and
colleges. We have made great progress in building a unified molecular biophysics community through a shared
mission of training the next generation of quantitative biomedical scientists. MBTP brings disparate groups
together and creates an integrated training experience, in which students from three different graduate programs
(Biophysics, the Ohio State Biochemistry Program, and the Chemistry Graduate Program) and many different
undergraduate majors learn from each other and from a broader group of mentors. All trainees obtain core
training in macromolecular and physical biochemistry, in the fundamentals of biophysics, and in the responsible
conduct of research with the highest standard of rigor and reproducibility. This breadth ensures that trainees can
communicate equally well about our most challenging biomedical problems and about the modern quantitative
and molecular methods to address these, while being responsible citizens and researchers. A coordinated plan
from a wide selection of elective courses ensures that students have enough depth to be successful in their
research projects. A monthly workshop series and a yearly symposium provide cohesion to the program and
incorporate unique training opportunities in career exploration, professional development, mentoring best
practices, and continuous engagement with ethics training. Here we propose to deepen and expand this project,
drawing in a large, diverse community of new young investigators in medicine and engineering as trainers,
training a larger though still highly diverse cohort of students, raising the rigor of quantitative skills, and expanding
focus areas to include cryo-EM and biomedical engineering. At the same time, trainers will engage in evidence-
based practices to elevate their mentoring skills. The resources invested in the program by NIH will be
augmented by the institution, together allowing us to recruit and retain the strongest interdisciplinary students
with greater inclusion of underrepresented groups. Guiding principles of excellence, collaboration and
interdisciplinarity, and diversity and inclusion are used to build on our original plan for the highest quality training,
research and career development for students of molecular biophysics.

Public health relevance
PROJECT NARRATIVE We propose a Molecular Biophysics Training Program (MBTP) that leverages the research and training experience of 27 faculty Trainers in three colleges and eight departments to create a unique training experience at the crossroads of the quantitative, molecular, and biomedical sciences. Students from three different graduate programs and many different backgrounds will have the opportunity to interact with and learn from each other and from the many experienced Trainers. This training will prepare graduates to address the biomedical challenges of the twenty--first century with truly collaborative and comprehensive approaches that address pressing needs in career development and inclusion of diverse groups.